REGULATION OF APOPTOSIS BY CELLULAR RAS ISOFORMS

The Ras family of GTPases are known to be critical in the transient activation of proliferative signals by extracellular mitogens. Oncogenic Ras proteins provide a constitutive, rather than transient signal, thereby resulting in cell transformation. Oncogenic Ras proteins can, in some instances, protect cells from apoptosis, primarily through the constitutive activation of PI-3 kinase and its downstream target, Akt. In other cases, oncogenic Ras can activate the apoptotic pathway, resulting in cell death. Using N-Ras and K(i)-Ras knockout cell lines, we have demonstrated that these proteins play a critical role in regulating apoptotic sensitivity in normal cells. In the absence of c-N-Ras expression, cells become hypersensitive to apoptotic agents, inclusive of TNFalpha, anti-Fas and serum-withdrawal. Ectopic expression of c-N-Ras in the N-Ras deficient cell lines restored their resistance to each of the apoptotic treatments. Ectopic expression of c-K(A)-Ras, however, failed to rescue the apoptotic sensitivity of the N-Ras knockout cell lines. In fact, expression of the K(A)-Ras protein enhanced even further the apoptotic sensitivity of the N-Ras knockout cell lines. Our preliminary data suggest that c-N-Ras deficiency results in a higher than normal level of mitochondrial instability. Raf-1, MEK1 and c-N-Ras are all found in a purified mitochondrial preparation, supporting our hypothesis that c-N-Ras plays a vital role in maintaining mitochondrial integrity. While N-Ras negative cells are hypersensitive to the induction of apoptosis, K(i)-Ras negative cells were more resistant than their cognate control cells (K+/+) to apoptotic agents, suggesting that cellular K(i)-Ras proteins provide a steady-state pro-apoptotic signal. We will test the hypothesis that endogenous cellular Ras isoforms (N, K(A), and K(B)-Ras) regulate the threshold that determines whether or not extracellular stimuli promote programmed cell death. We will test this hypothesis through the execution of the following specific aims: 1. We will determine which well-defined apoptotic components are altered by the lack o c-N-Ras expression. 2. We will characterize the requirement for cellular K-Ras proteins in sensitizing fibroblasts towards apoptotic signals. 3. We will perform structure/function analysis on the variable regions between N-Ras K(A)-Ras and K(B)-Ras to determine specific regions within these proteins which define their opposing functions in regulating cellular sensitivity towards apoptotic agents.